RoseTTAFold and AlphaFold modeling

Project summary
This administrative supplement is to obtain a necessary system for computational analysis.
Recent advancements in in silico protein structure prediction as demonstrated by the AlphaFold
and RosettaFold offer promising opportunities to straighten the ongoing project. We aim to
materialize these opportunities with this administrative suppoement.

Public health relevance
Project narrative We aim at predicting gating conformational changes in TRPV1 with greater accuracy to complement functional analyses.